BCCMA: Foundational Research to Act Upon and Resist Conditions Unfavorable to Bone (FRACTURE CURB)

To ensure aging Veterans remain active and mobile with as little musculoskeletal pain as possible, new
approaches to the prevention of osteoporosis and promotion of timely bone regeneration following a fracture are
necessary. This collaborative research study brings together a group of VA investigators with diverse
perspectives, insights, models, and techniques, to synergistically attack a major clinical problem that leads to
high morbidity and mortality among Veterans, a bone fracture. The overall research strategy of each integrated
project is to use pre-clinical models of a disease that either weakens bone or delays bone repair, to investigate
novel ways to enhance the ability of parathyroid hormone (PTH) to promote bone formation, and to assess
disease and treatment effects on bone in a unified, stringent manner. Already under-diagnosed and under-
treated, osteoporosis is likely to increase the number of fragility fractures being treated at VA hospitals without
novel tools for early detection and novel treatment strategies that circumvent the rare but devastating side effects
of current therapies that inhibit bone loss. Addressing this unmet clinical need, the overall aims are to identify
therapeutic strategies to improve bone health among Veterans and to enhance the bone anabolism of PTH
signaling. The collaboration will address this overarching hypothesis: health problems disproportionately
affecting Veterans activate signaling pathways that increase bone resorption, suppress bone formation, or
impede the transition of cartilage to bone in a fracture callus such that improvements in the clinical management
of osteoporosis lie in understanding how these health problems hurt bone health.
The project “PTH receptor Signaling and Diabetes-Induced Bone Disease” will test the hypothesis that diabetes
(DM) triggers Nox-mediated ROS distress and lipid accumulation in bone, which impact bone formation and
material properties; and that these effects are reversed by activation of the PTH Receptor (PTH1R)/SIK axis in
osteocytes. This hypothesis will be tested using a preclinical model of established DM, bones from diabetic
patients, FDA-approved PTH1R ligands PTH and ABL, the orally available SK-124 inhibitor, and molecular,
cellular, and tissue-level advanced approaches. Aim1 will establish the contribution of Nox/ROS distress and
cellular cholesterol/lipid accumulation to DM bone disease. We will determine whether DM-induced bone disease
is prevented by 1a) interfering with Nox-mediated ROS in mice with loss of function of the CYBA gene/p22phox
protein and/or 1b) increasing ABCA1-mediated cholesterol/lipid efflux pharmacologically with the liver X receptor
(LXR) agonist GW3965. Aim2 will identify the target cell(s) in bone/marrow mediating the crosstalk between DM
and PTH1R/SIK axis. We will establish cell population profiles, gene expression, and pathway enrichment
analysis in bone/marrow cells by single cell RNA sequencing (scRNAseq), validated by targeted gene expression
(NanoString) and tissue-spatial transcriptomics (GeoMx). We will use bones from DM mice treated with PTH/
ABL/SK-124; and from control/diabetic patients subjected to hip replacement. Aim3 will determine the role of
osteocytes in bone material properties restoration by the PTH1R/SIK axis. We will investigate changes in bound
water, Glycosaminoglycans (GAGs) composition, and Advance Glycosylation End Products (AGEs), using
osteocytic PTH1R knockout mice. Aims1-3 and Aim2 will be supported by the Bone Quality Core and the
Molecular Biology and Histology Core of the FRACTURE CURB, respectively. Successful completion of the
proposed studies will reveal novel genes, pathways, and cells to be therapeutically targeted downstream of
PTH1R signaling to counteract diabetes-induced bone disease, thus contributing directly to the purpose of the
FRACTURE CURB of improving bone health in Veterans.

Public health relevance
This proposal addresses a significant health problem globally, and in the US Veteran community, which is the bone disease induced by diabetes (DM), a nationwide epidemic declared by the American Diabetes Association. Within the general population, 1 year after suffering a hip fracture, 25% of patients will die, 30% will suffer a permanent disability, and 40% will be unable to walk independently. Diabetic patients exhibit >30% increase in bone fracture risk compared to non-diabetics. Thus, morbidity and mortality due to bone fractures are significantly augmented in DM. Successful completion of the proposed studies will reveal novel genes, pathways, and cells to be therapeutically targeted downstream of PTH1R signaling to restore skeletal health in the frame of DM, advancing the development of strategies to increase fracture resistance and improve bone health in Veterans.